Eukaryotic Protein Maturation and Transport

Control of entry of molecules to the cell is fundamental to cellular health as is ensuring that proteins are correctly folded and incorporated in the right cellular compartment. We are using structural biology to dissect the membrane proteins that achieve these goals. This year we have published structures that now form the start point for larger studies of drug-bound forms that will enable redesign of therapies for both cancer and novel anti-bacterial agents. Additionally, we have extended our work to delineate the structural basis for the association with disease of expansions of the HTT protein in Huntington's Disease.